Systemic Nanocurcumin for Pancreatic Cancer Therapy

Curcumin, a yellow polyphenol compound found in the Indian spice turmeric (Curcuma longa) demonstrates potent anti-cancer effects against a wide variety of human tumor models in preclinical studies. A major pitfall forthe application of curcumin to human cancer therapy has been its limited systemic bioavailability, such that the few clinical trials conducted so far had administered

Public health relevance
The clinical translafion of the promising anti-cancer agent curcumin has been hampered due to poor absorpfion from the gut. We have generated a nanocurcumin formulation that, for the first time, bypasses this major pitfall, and has the potenfial to enable widespread application of curcumin to cancer therapy. The studies proposed herein are focused on generating the efficacy and toxicity required to begin clinical trials.